Community-Engaged Intervention to Optimize the Impact of RenovatedNeighborhood Parks on Community Wellbeing

Project Summary
Parks are a key feature of the built environment that foster community engagement, make communities vibrant,
and support resident wellbeing. This study will test the impact on community-level health-related quality of life
and mental health of a community-engaged, community-level intervention that aims to improve park-based
health and social programming. The study will leverage neighborhood parks that have recently been redesigned
and renovated as part of the Community Parks Initiative, a capital investment and park equity program in New
York City. We aim to work with eight lower income and predominantly Latino and Black neighborhoods through
an asset-based and human-centered design process to co-create and implement one health and one social
strategy in each neighborhood park. The health strategy will focus on physical activity and the social strategy will
seek to enhance social relationships and networks in each neighborhood. Achieving broad reach, inclusivity, and
sustainability are key factors that will be taken into account in the design process. The eight neighborhoods will
be cluster-randomized to one of two steps in a stepped wedge intervention trial. The intervention is 24 months
in each community, with follow-up to 48 months. We will study outcomes, including HR-QoL, depression,
anxiety, stress and loneliness, at the community level (not among individuals participating in park activities) via
random, representative samples of adult residents in participating communities at intervention baseline and
months 24 and 48 post-baseline.In addition, we will examine whether the intervention effects might be mediated
through social cohesion, neighborhood ties, sense of community, park use and perception and/or health
behaviors such as physical activity and sleep. Finally, we will conduct qualitative research to examine the
implementation of the community-level intervention based on constructs from the Consolidated Framework for
Implementation Research. Study findings will help inform future best practices in urban community
development and park programs and policies to promote population health and reduce health disparities.

Public health relevance
Project Narrative Given parks’ importance for community engagement, vibrancy and wellbeing, we will implement a community engaged, human-centered design-driven intervention that empowers and capacitates stakeholders in predominantly Black and Latino communities to design and implement health and social strategies in newly renovated parks as a way to enhance the social environment of neighborhoods. We will determine the impact of this intervention on community-level health-related quality of life and mental health. This innovative study will inform new models of community engagement, community development and park-based programs and policies to promote population wellbeing and reduce health disparities.